Reducing Veterans' Risk of Atherosclerotic Cardiovascular Disease Through Pharmacogenomics Informed Statin Prescribing

Background: Despite the proven efficacy and safety of statins, nearly 250,000 Veterans at high-risk for
cardiovascular disease (CVD) seen annually in primary care are not taking them leading to higher cholesterol
levels, cardiovascular risk, and health care costs. Primary care providers and health systems have a critical
and unmet need for pragmatic, scalable interventions to address gaps in their patients’ perceptions of the risks
and benefits of statin therapy to improve appropriate statin utilization and to lower CVD risk. Important prior
work by our group demonstrates that pharmacogenomic testing for statin toxicity is feasible, improves patients’
perceptions of statin therapy, leads to a doubling in appropriate statin prescribing, and lowers cholesterol
levels. The central hypothesis of this proposal is that disclosure of statin pharmacogenomic test results for
statin efficacy/toxicity and CVD risk to patients at high-risk for CVD will improve their perceptions of their CVD
risk and statins risks/benefits and, in turn, the proportion of Veterans accepting and adhering to statin therapy
to achieve a clinically significant low-density lipoprotein cholesterol (LDL) reduction.
Significance: By using a feasible and inexpensive approach of pharmacogenomic testing for common genetic
variants reporting on statin efficacy and toxicity and CVD risk, the work is significant as it will lead to more
patients at high-risk for CVD accepting and adhering to statins. This work addresses HSR&D research
priorities of quality and safety of health care and health care value, ORD priorities of increasing substantial
real-world impact of VA research, and VHA quality measures around statin prescribing and controlling
cholesterol levels in patients at high-risk for CVD.
Innovation and Impact: This proposal uses an innovative approach of pharmacogenomic testing to address
patients’ perceptions of the risks and benefits of statin therapy and their risk of CVD which are known barriers
to statin acceptance and adherence. We expect a positive impact on reducing CVD risk in Veterans.
Specific Aims:
1: Reduce cholesterol levels through a precision medicine approach of statin pharmacogenomic testing.
2: Improve acceptance of guideline-directed statin therapy through delivery of statin pharmacogenomic test
results that communicates statin efficacy and toxicity.
3: Identify contextual and economic factors salient for implementing statin pharmacogenomic testing.
Methodology: A randomized controlled trial focused on effectiveness while secondarily gathering
implementation data will enroll 408 primary care patients who are at high-risk for CVD and recommended for
statins based on guidelines but not prescribed them. Participants will be randomized 1:1 to intervention
(guideline-based statin recommendations - “guidelines” - plus statin pharmacogenomic test results) vs. control
(guidelines) stratified by prior statin use. The primary outcome is change in 12-month LDL. Secondary
outcomes are new statin prescriptions and patients’ perceptions of risks and benefits of statins. Exploratory
analyses will assess statin prescriptions and fills as potential mediators of the intervention. Qualitative data
from trial participants and their providers will illuminate key factors to consider for future implementation. If
effective, the cost-effectiveness and budget impact of the intervention on LDL during the trial period projected
over 10-year and lifetime CVD risk horizons will be measured.
Next steps/Implementation: An embedded primary care, patient-powered caucus and a VA operational
stakeholder board representing primary care, cardiology, pharmacy, and the VA Pharmacogenomics Testing
for Veterans (PHASER) clinical program will work with the investigative team to create an implementation
“blueprint” package consisting of patient/provider educational portfolios, electronic medical record tools,
Corporate Data Warehouse queries, and laboratory protocols for dissemination to Veterans and VHA facilities.

Public health relevance
Statins are the most cost-effective medications to lower cholesterol and cardiovascular disease (CVD) risk. However, many patients at high-risk for CVD do not accept or adhere to statins. This gap in patient’s use of statins limits the full impact of these effective medications resulting in higher cholesterol levels and CVD risk. The main barriers to using statins are patients’ perceived lack of benefit, excess risk of statin toxicity as well as their misperceptions of their CVD risk. Statin pharmacogenomic testing – an application of precision medicine – is a readily available, feasible, and inexpensive intervention that addresses this barrier by using genetic testing to identify the nearly 1 out of 2 patients with enhanced benefit and/or reduced risk of statin toxicity or increased risk for CVD. By communicating statin pharmacogenomic test results to Veterans at high- risk for CVD not taking statin therapy, we aim to improve patients’ perceptions of their risk of CVD and statins and, in turn, their acceptance of and adherence to statins to reduce their cholesterol levels and CVD risk.